Computer Integrated Systems for Microscopy and Manipulation

DESCRIPTION (provided by applicant): The hallmarks of like - motility, adaptation and replication - occur because molecules as Individuals and organized into cells and tissues, generate and respond to forces. The coordinated activity of thousands of molecular motors within single cells oscillates cilia to cause the flow of the pulmonary barrier fluid over long distances. Infection, Inflammation, and metastasis involve the motility of single cells moving through internal changes of shape with forces pushing against their own membranes, peeling, pulling, and rolling with specific proteins in the lumen of blood vessels, or propelled by polymerization of molecular units. Replication involves the wholesale rearrangement of chromosomes through the mitotic spindle, generating forces to organize the chromosomes along the midplate, sensing forces to pass through the checkpoint to finally pull the kinetochores poleward with polymerization forces. Over the past decade the advances in structure identification through genomics and proteomics has been matched by exquisite tools for understanding function through forces. The goal of our resource is to develop force technologies to be applied over a wide range of biological settings, from the single molecule to the tissue level, with integrated systems that orchestrate facile control, multimodal imaging and analysis through visualization and modeling. The individual collaboration projects that steer our technology development cover a wide range of phenomena in molecular biophysics, cell biology and biomedical science. They cover length scales ranging from single molecule (mucin, myosin, MutS) to macromolecular complexes (fibrin fibers, viruses), cells (Plexin, cell motility, cell division), tissue cultures (human lung cell cultures) and macroscopic biomaterial properties (mucus rheology).

Public health relevance
RELEVANCE (See instructions): Our Resource develops new instrument technologies for enabling flexible force measurements. Including magnetic technologies, integrated atomic force and fluorescence microscopy, and development of software to control magnetic fields and tracking. We continue to bring cutting-edge devices, techniques, and research in computer science to bear on biomedical research, design and implement techniques to display models and real-time simulations aligned in space and time with experimental results.